Modeling the development of orientation selectivity, maps, and the associated recurrent circuit

ABSTRACT
Much evidence suggests that the development of orientation selectivity and maps in primary visual cortex (V1)
is instructed by spontaneous patterns of input activity, without the necessity of visual experience. Evidence also
suggests that this development is driven by a competition between ON- and OFF-center inputs, that leads
individual cortical cells to become "simple cells", meaning they receive inputs from retinotopically adjacent
subregions of ON-center and OFF-center inputs.
A prominent model proposed statistics of spontaneous input activity that would lead to that outcome through
"Hebbian" plasticity, in which "neurons that fire together wire together". But experiments have shown that those
statistics are not present.
We have discovered how the observed statistics can lead to development of simple cells. We now propose to
build on that model to account for development of map organization, ON-dominance and anchoring of receptive
fields, feature-specific recurrent connectivity, co-tuning of excitation and inhibition received by cells, and other
observed phenomena. We will build on our own discoveries of cortical connectivity that produces many nonlinear
cortical response properties, and the discoveries of others on the outcomes of co-development of feedforward
and recurrent connections. In so doing we aim to build a comprehensive account of the mechanisms leading to
the V1 circuitry that yields orientation selectivity and orientation maps as well as a variety of nonlinear response
properties.

Public health relevance
NARRATIVE The activity-dependent development of orientation selectivity and maps is a canonical problem for understanding cortical development and learning. Current explanations of orientation selectivity have been contradicted by experiment, and also present key problems for understanding map formation. We will develop a theory that solves these problems and addresses a number of other phenemona in development such as development of selective recurrent connectivity with co-tuned excitation and inhibition.